A prospective multiethnic HFpEF cohort from California's Central Valley

ABSTRACT
This is a new U01 application to establish a Clinical Center (CC) for a prospective multiethnic HFpEF cohort
from California central valley for deep phenotyping analyses. The investigative team is diverse,
multidisciplinary, and complementary with investigators from School of Medicine, College of Engineering and
College of Agricultural and Environmental Sciences. The investigative team is highly collaborative and has
strong track records of previous participation in large-scale research networks involving electronic data from
heterogeneous sources, including EHRs, mobile health technologies, and direct-to-participant mailings/web
portals. UC Davis Heart Failure Network has one of the most diverse patient population in the country, with a
large representation of Latino population from California Central Valley. Our network has an extensive
catchman area with a momentous growth in patient volume. The proposed deep phenotyping will take
advantage of the newly developed total-body PET scan at UC Davis to decipher the roles of organ-specific
variations in metabolic syndrome and inflammation in a diverse and heterogenous HFpEF population. One
unique feature of the proposed study is the use of functional connectomics analyses to directly exploit the
heterogeneity in the HFpEF population. Indeed, it is the heterogeneity that provides the necessary data
needed to derive the interconnections to test the critical network drivers, that will provide eventual insights into
potential molecular targets for therapy as well as the unbiased classifications of subtypes of HFpEF. Finally,
functional connectomics analyses enable modular “plugin” of new datasets (e.g., microbiomes), derived from
deep phenotyping analyses from other CCs in the HeartShare Network. Therefore, our proposed study
promises to contribute both technically and conceptually to the overall understanding of the molecular
mechanisms underlying the heterogenous disease in HFpEF.

Public health relevance
Project Narrative This is a new U01 application to establish a Clinical Center (CC) for a prospective multiethnic HFpEF cohort from California central valley for multiscale novel deep phenotyping analyses. Our proposed study promises to contribute both technically and conceptually to the overall understanding of the molecular mechanisms underlying the heterogenous disease in HFpEF.